Overcoming resistance to KRAS inhibitors through a fragment-based chemoproteomics approach

Abstract
A major breakthrough in recent years has been the development of selective inhibitors that target KRASG12C
mutations found in lung, colon, and other rare cancer typ. Both sotorasib and adagrasib have response rates of
nearly 40% in KRASG12C mutant lung cancer. Despite this advance, there remains two major problems to
address. First, a substantial group of patients fail to have tumor regressions. Second, the responses are
transient, with the emergence of resistance leading to tumor progression. While genomic mechanisms have
been identified that drive acquired resistance, a sizeable group of tumors lack obvious genomic mechanisms
and appear to rely on transcriptional reprogramming or epigenetic mechanisms. We have generated cell line
models that recapitulate non-genomic mechanisms of resistance to (i) identify such targets associated with
resistance and (ii) develop lead compounds to serve in future drug discovery efforts. To identify both new targets
and lead compounds, we will leverage a new fragment based chemoproteomics approach. Fragment-like probes
have the distinct advantage over larger, more decorated drug-like molecules because of their (i) smaller size and
(ii) simpler structures that can engage target binding sites that are inaccessible to more developed and complicated
molecules.Thus, fragment-like molecules are unique tools to identify novel targets and probe uncharted biological
target space. Our preliminary data in Sotorasib resistant cell models indicates the ability of this screen to identify
fragments with enhanced activity in the resistant cells compared to drug sensitive parent. In addition, using a
group of functionalized 20 fragments, we demonstrate in the KRASG12C mutant H1792 cell the ability to identify
targets of these fragments using chemical proteomics. Aim 1 will test the hypothesis that we can identify
fragments that have enhanced activity in the Sotorasib resistant cells compared to untreated drug sensitive cells.
We will leverage additional cell line models of Sotorasib resistance, and use non-KRASG12C mutant lung cancer
models and non-tumor lung epithelial cells to enhance selectivity. Aim 2 we will test the hypothesis that targets
that drive the resistant phenotype can be identified by chemoproteomics. We will assess targets in our 20
functionalized fragment library as well as assess targets identified in our larger fragment screening. By using
this approach that enables probing a significantly larger biological target space, we expect to identify unique
targets for KRASG12C inhibitor resistant cells. At the same time, our approach will identify chemical leads engaging
these targets for future dedicated drug discovery projects.

Public health relevance
Narrative This project will use a fragment based chemoproteomics approach to discover new targets that mediate resistance to KRAS inhibitors and at the same time deliver new lead compounds.